BMP and Notch crosstalk in cerebral arteriovenous malformations

SUMMARY
Cerebral arteriovenous malformations (AVMs) are the most common vascular malformations and the leading
cause of hemorrhagic strokes. Past studies have demonstrated an important role of endothelial cells (ECs) in
cerebral AVMs, and shown that the maintenance of endothelial integrity by bone morphogenetic protein (BMP)
and Notch signaling is critical for cerebral vascular formation. However, it is unclear how disturbed crosstalk
between BMP and Notch signaling affects EC differentiation at transcriptional regulatory level causing cerebral
AVMs. In this proposal, we aim to unearth that the crosstalk between BMP and Notch signaling induces histone
deacetylase 2 (HDAC2) to shift the transcriptional landscape of ECs toward ill-fated differentiation causing
cerebral AVMs. We will also define if HDAC2 inhibition prevents this ill-fated cell shift and improves cerebral
AVMs. In preliminary study, using a new mouse model, we find a striking shift of ECs to mesenchymal-like cells
in cerebral AVMs and show that these mesenchymal-like cells cause arteriovenous shunts. Utilizing single-cell
RNA sequencing and connectivity Map, we identify HDAC inhibition to prevent ECs from mesenchymal cell
differentiation and significantly reduce cerebral AVMs. In human and mouse cerebral AVMs, we find a specific
HDAC2 induction. We show that HDAC2 induction alters specific histone modifications, which are responsible
for the shift of ECs to mesenchymal cell differentiation. Endothelial-specific deletion of HDAC2 prevents this ill-
fated cell shift and reduces cerebral AVMs. Similar results of dysregulated HDAC2 with its downstream effects
are also found in cerebral AVMs of hereditary hemorrhagic telangiectasia type 1 (HHT1) and type 2 (HHT2), but
not in juvenile polyposis/HHT. Furthermore, we find that HDAC2 is specifically induced in cerebral AVMs by
excess BMP through delta-like protein 3 (Dll3) and Notch1 signaling. We uncover that lack of matrix Gla protein
(MGP) allows BMP-8b to elevate staphylococcal nuclease domain-containing protein 1 (SND1), which is required
for Notch signaling to induce HDAC2 in cerebral AVMs. We hypothesize that HDAC2 induction, downstream of
excess BMP and Notch signaling, alters specific histone modifications to shift ECs toward ill-fated differentiation
causing cerebral AVMs. In specific Aim 1, we will determine how HDAC2 is dysregulated by the crosstalk
between BMP and Notch signaling and shifts endothelial differentiation in cerebral AVMs. In specific Aim 2, we
will determine the contribution of HDAC2 induction to human cerebral AVMs. In specific Aim 3, we will determine
if limiting HDAC2 improves cerebral AVMs. If successful, the obtained information will provide new insight into
the mechanism of AVMs, and HDAC2 inhibition may emerge as a novel therapeutic approach for cerebral AVMs.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Our studies are relevant to the diseased vessels in the brain, so-called cerebral arteriovenous malformation. This study focuses on factors referred to histone deacetylase 2, bone morphogenetic proteins and Notch, and how they communicate with each other to regulate vessel lumen and vessel lining. Understanding how these factors work may lead to new strategies for prevention and treatment of arteriovenous malformation.